Sample Processing and Analysis Core

The purpose ofthis core Is to provide a cen tialized laboratory resource for cryopresen/ation and distiibution of patient samples to program investigators. The core virtll also maintain an annotated database with relevant pathologic data for each sample and develop genomic and functional assays to support clinical investigation. This core has 4 Specific Aims: 1. To acquire primary leukemia samples from p atients ente red in clinical research protocols and to isolate and preserve RNA, DNA, and viable mononuclear cells. 2. To maintain an annotated database containing pathologic, cytogenetic and molecular infomiation for clinical samples obtained from patients witii myeloid leukemias. 3. To develop a set of standardized genomic and functional assays to support clinteal investigation. 4. To maintain a bank of AML cell lines optimized for in vivo studies and a bank of AML

Public health relevance
This core will be responsible for obtaining blood and marrow samples from patients with myel old leukemia and maintain a repository virith Vn ese leukemia samples. Patient confkjentiality vM be maintained and samples will only be ob tained from patients who have provided inform ed consent. These samples will be provkled to program investigators for research studies outlined in each projecl This core will also use these samples to tievelop and carry out genetic and functional assays.